Social Determinants of Health, Asthma-Related Morbidity and Therapeutic Optimization for Black and Latinx Adults with Asthma

Summary: Asthma is a common chronic airway disease that affects 21 million adults in the US with substantial
morbidity and healthcare costs. Black and Latinx adults bear a disproportionate share of that burden of
disease, partly due to an inequitable distribution of social determinants of health (SDOH). SDOH have 5
components: 1. economic stability, 2. education access and quality, 3. health care access and quality, 4.
neighborhood and built environment and 5. social and community context. Attempts to improve asthma
outcomes in these populations have mostly been unsuccessful partially because the relationship between
SDOH and in Black and Latinx adults with asthma is insufficiently understood. These groups have been vastly
underrepresented in research intended to mitigate health disparities, limiting the ability to disentangle the
complex relationship that these racial and ethnic groups have with SDOH in the US. The few studies that did
so were conducted in children, had limited, retrospective, or cross-sectional asthma outcomes data, or
unidimensional SDOH data. Addressing this knowledge gap is critical to the implementation of high-yield policy
and interventions that will reduce the burden of disease for these vulnerable populations. In a large pragmatic
randomized controlled trial (the PREPARE study), our group collected extensive demographic, clinical, and
phenotypic data in addition to prospective asthma morbidity outcome data through monthly surveys. We
successfully showed that a ‘Patient-Activated, Reliever-Triggered Inhaled CorticoSteroid’ (‘PARTICS’) strategy
plus usual care reduced asthma exacerbations in 1,201 Black and Latinx adults with moderate-severe asthma
vs. usual care alone. We also showed that low socioeconomic status (SES) associates with worse asthma
morbidity using a multidimensional SES latent variable (defined by poverty, low educational attainment, and
unemployment), structural equation modeling and mediation analysis on retrospective baseline data among
Black and Latinx PREPARE participants. We also found that Caribbean Latinx adults experience greater
asthma morbidity vs. other Latinx subgroups, supporting our overall hypothesis that a distinct set of SDOH
exposures (an SDOH exposome) within racial or ethnic groups may impact asthma outcomes. The richness of
our PREPARE dataset, enhanced with our ability to analyze geocoded data on all 5 SDOH components,
uniquely enables us to address these Specific Aims: Aim 1a: To determine whether Black vs. Latinx adults
with moderate-severe asthma have unique SDOH exposomes that distinctly associate with worse asthma
morbidity. Aim 1b: To determine whether African American vs. non-African American Black adults experience
greater asthma morbidity. Aim 2: To determine baseline SDOH exposomes and clinical characteristics that
predict optimal PARTICS responders. Results from this R21 award may identify unique SDOH exposomes for
Black and Latinx adults that lead to high-yield interventions, plus facilitate our work implementing the PARTICS
strategy, both of which may reduce morbidity in these highly impacted populations.

Public health relevance
Narrative: Black and Latinx adults bear a disproportionate share of the burden of disease from asthma but attempts at reducing this disparity have mostly been unsuccessful partly due to an insufficiently understood relationship with social determinants of health (SDOH). Our group demonstrated in a large pragmatic clinical trial (the PREPARE study) that a ‘Patient-Activated, Reliever-Triggered Inhaled CorticoSteroid’ (‘PARTICS’) strategy added to usual care successfully reduced asthma attacks in 1,201 Black and Latinx adults with moderate-severe asthma relative to usual care, and in doing so created a rich dataset of demographic, clinical, and phenotypic data, now enhanced with geocoding data available from participants’ zip codes—a wealth of data on two racial and ethnic groups for whom there is few clinical research studies available. We now have an opportunity with the richness of our dataset to identify unique sets of SDOH characteristics for Black and Latinx adults that may lead to high-yield interventions, plus facilitate our work implementing the PARTICS strategy, both of which may reduce morbidity in these two highly impacted populations.